Pressure Regulation of Human Trabecular Meshwork Genes

ABSTRACT Glaucoma is an optic neuropathy which causes irreversible blindness. Our approach to study glaucoma consists of selecting a well-established clinical condition associated with the disease and investigating the clinical parameter at the molecular level. Elevated intraocular pressure (IOP) is the major risk factor for the development of glaucoma. In humans, 90% of the aqueous humor exits the eye through the trabecular meshwork (TM). Thus, a dysfunctional TM results in increased resistance and elevated IOP. Because the physiology of a tissue is governed by the expression of its genes, during the previous grant cycle we examined TM differential expression under conditions of elevated IOP. After analyzing many chip arrays comparing normal and high IOP perfused post-mortem human eyes, we unraveled a number of genes involved in calcification processes. We further uncovered that such processes were not only present in the TM, but also that they seemed to be more active in TMs from glaucomatous patients. Based on these findings, we hypothesize that TM calcification is linked to regulation of IOP and outflow facility. That genes and mechanisms that govern physiological and pathological calcification in the bone and vascular tissues are active in the TM, and that these processes, as well as efforts to inhibit them, are part of the regulatory systems that control aqueous humor outflow. We further hypothesize that failure to maintain TM mineralization in check will affect deposited collagen and elastin cross-linking with deleterious consequences to ECM hardening. To test these hypotheses we propose to further characterize the identified mechanism through three new avenues. The first will investigate the phenomenon in vivo, through the use of transgenic mice. The second will investigate the process in human organ cultures. The third will use primary human TM cells to determine the involvement of two pathways (WNT and LOX-related elastin/collagen cross-linking) in TM mineralization. These two pathways have been independently associated with vascular calcification and osteoblastic differentiation and, with conditions affecting TM function. Results to be obtained with the development of these hypotheses will provide new understanding on the mechanisms regulating outflow resistance and would potentially lead to new treatments for glaucoma.

Public health relevance
PROJECT NARRATIVE Glaucoma is the second leading cause of irreversible blindness and the most common cause among African- Americans. Currently, there is no cure for glaucoma. Elevated intraocular pressure (IOP) is the major risk factor for the developing of glaucoma. IOP is maintained by the resistance of the trabecular meshwork to the flow of aqueous humor. The goal of our project is to investigate the relevance of a previously undescribed process of mineralization occurring in the trabecular meshwork for the regulation of IOP. The trabecular meshwork needs to have in place molecular mechanisms that would maintain the physical properties of elasticity, tension and softness. Maintenance of the softness is of highest relevance to the trabecular meshwork's function. Pathological calcification occurs in soft tissues and has important clinical implications. Ectopic calcifications are well known to occur in cardiovascular diseases, atherosclerosis, arthritis, kidney disease and cancers. Vascular calcification decreases elasticity of the blood vessels and increases their brittleness, leading to increase risk of arterial rupture. In this project we aim to characterize this process in the eye of transgenic animals, human eyes from post-mortem donors and primary trabecular meshwork cells obtained from residual tissue after corneal transplants. We will aim to further study the role of inhibitors of calcification in the trabecular meshwork and ultimate open a new door for the development of new treatments for Glaucoma.